Effects of paternal aging on male reproductive biology and on future generations

Project Summary/Abstract
Over the past century, a marked demographic shift in the United States and other
wealthy countries has lead to childbearing occurring later and later in life. In addition to
the decrease in fecundity that accompanies aging, there is accumulating evidence that
paternal age can impact offspring health and disease. This has typically been attributed
to the effects of advanced paternal age on genetic changes in sperm that are transmitted
to children. Here, we consider an underappreciated possibility – that the aging process
affects epigenetic information carried in sperm, with resulting “epimutations” being
responsible for the altered phenotypes that manifest in the next generation.
Here, we propose to investigate the effects of aging on key male reproductive
tissues, including the testis, epididymis, seminal vesicle, and prostate. We will explore
the effects of advanced paternal age on a variety of behavioral and metabolic traits in
offspring, and will comprehensively analyze molecular differences between sperm
obtained from young and old animals.
Together, these experiments systematically address the effects of aging on male
reproductive function and on future generations, and may provide therapeutic avenues
for mitigating the effects of delayed paternity on disease risk in children.

Public health relevance
Public Health Relevancy Statement/Project Narrative Lifestyle and career changes in the Western world have lead to couples putting off childbearing until later in life. Not only is time to conception delayed in older men, but it is increasingly clear that children of older men are at increased risk for certain neurodevelopmental diseases. Here, we propose to thorouhgly investigate the effects of advanced age on the male reproductive tract, focusing not only on the testis but also on understudied male reproductive tissues of relevance to fertility including the epididymis and seminal vesicle. We will also investigate changes in behavior and metabolism in offspring of older males, and will characterize the changes in the sperm epigenome that might explain these changes. These studies will be of great importance for understanding how male reproductive function changes with age.